Returning Individual Genetic Research Results to Parents and Children

DESCRIPTION (provided by applicant): This application addresses broad Challenge Area (02) Bioethics, 02-HL-101: Informing the ethical and practical guidelines for providing genetic research results to study participants. The mapping of the human genome has allowed researchers to discover new relationships between genotype and phenotype, and has provided the basis for genome-informed medical decision-making that will lead to diagnoses and therapies that are targeted, have reduced variability, maximize efficacy, and minimize adverse effects. As information of greater health significance is generated by genomic research, there is an emerging consensus that the ethical return of genomic information will be needed. The goal of this proposal is to understand the attitudes of participants in genomic research towards the return of research results in the setting where the participant is a child and the receiver of the information is the parent. We will take advantage of a large genotype-phenotype project initiated by our group at Children's Hospital Boston (CHB) based on the Informed Cohort, a new paradigm for genomic research that we developed. The Informed Cohort is a model for the ethical recruitment of participants into a longitudinal genotype-phenotype registry and reconciles the "paradox" of maintaining participant privacy, yet providing results. We call the implementation of the Informed Cohort model at CHB the "Gene Partnership Project" (GPP). GPP is a longitudinal genotype-phenotype registry that uses a messaging system through the CHB personally- controlled health record (PCHR) to facilitate the disclosure of research results back to the participants. The "Informed Cohort Oversight Board" (ICOB) will provide the crucial oversight of the communication of results back to participants. While the enrollment of children might seem to present additional ethical obstacles, we see the natural participation of the "family unit" that occurs in pediatric hospital as an advantage for GPP. While we have implemented GPP, we do not know what factors will maximize its benefit and appeal for participants and families. We therefore propose a multi-step evaluation of the GPP and the messaging system. We do not know how parents view studies where they receive research results back on their children. To address this issue we will assess the interest of parents to participate in a genotype-phenotype study focused on their children, and determine if they would want to receive genetic information back from the study about their child. We also do not know how participants will perceive the messaging when it occurs. Thus, we will assess the use of the PCHR-based messaging system by parents of participants enrolled in GPP. Finally, a functioning ICOB will be paramount for the process of returning research results to be successful, yet we do not know how the ICOB will function. Since further work is required to ensure that the ICOB is a workable model for decision-making, we will develop the "Informed Cohort Oversight Board". The knowledge gained from the proposed project on the ethical return of research results to participants will be critical as we move towards a paradigm where individuals directly benefit from the genomic research they participate in, and eventually from genomic medicine. This project addresses the ethical issues associated with the return of genetic information to the parents of children participating in genomic research. It is critical that participants in genomic research benefit from the studies that they are participating in, especially if there are research results that pertain to their current or future health. Yet the return of such research information needs to be done in a manner that assures validity of the results, and is thoughtful and sensitive. The goals of this project are to understand parental attitudes toward receiving genetic research results back on their children, and to determine the effectiveness of an oversight board that will address the questions of how to ethical return results to participants. This study will be important as genetic research moves towards participants truely realizing the benefits of the research they are a part of.

Public health relevance
PROJECT NARRATIVE This project addresses the ethical issues associated with the return of genetic information to the parents of children participating in genomic research. It is critical that participants in genomic research benefit from the studies that they are participating in, especially if there are research results that pertain to their current or future health. Yet the return of such research information needs to be done in a manner that assures validity of the results, and is thoughtful and sensitive. The goals of this project are to understand parental attitudes toward receiving genetic research results back on their children, and to determine the effectiveness of an oversight board that will address the questions of how to ethical return results to participants. This study will be important as genetic research moves towards participants truely realizing the benefits of the research they are a part of.